The HarmonAIze Project: Pioneering Automated Climate and Health Data Harmonization and Integration

Project Summary
An effective and efficient response to climate change and other major public health threats in Africa requires
the optimal use of existing and routinely collected data, in accordance with the WHO FAIR principles. The DS-I
Africa initiative, and other projects and programs, have made significant progress in addressing barriers to data
sharing. Progress in upscaling data harmonization has, however, lagged considerably. The HarmonAIze
project addresses this key obstacle to realizing the potential of data science and Artificial Intelligence to
advance climate change and health research, and public health more broadly, in Africa and, indeed, globally.
The overall objective is to render data harmonization and climate integration more feasible, while optimizing
the inputs of health, data science and climate science experts.
Firstly, we aim to develop an open-source toolkit that leverages Artificial Intelligence to facilitate semi-
automated harmonization of health data, using large-language models to perform repetitive tasks that currently
require significant time and specialist expertise. Advances in the underlying methods will be supported by a
human-in-the-loop, judiciously utilizing domain-specific experts, while reducing common barriers to their
involvement in data science approaches. Achieving this will accelerate progress in the HE 2AT Center, but
importantly will also contribute to similar global projects, and, in fact to research on any health data reanalysis.
Secondly, the toolkit will perform spatiotemporal integration of climate and health data, leveraging advances in
African-optimized, semi-automated, geocoding pipelines and curated, downscaled, remote sensing climate
data. This approach allows for a federated approach to preserve data privacy. Additionally, this harnesses the
experience and expertise developed within the HE2AT Center to catalyze climate and health research on the
continent and beyond. We aim to pilot the approach through the DS-I Africa Research Hubs, initially UZIMA-
DS and MADIVA, contributing to a critical mass of climate-health researchers in Africa.
Thirdly, to achieve these ambitious goals, we will place an emphasis on capacity building within the HE2AT
Center and partners, focusing on early-career investigators and transdisciplinary collaboration across the
continent within the supportive scaffold of the Research Hubs, and Training Programs.
Lastly, we will collaborate with the eLwazi Open Data Science Platform, in the pursuit of establishing a Center
of Excellence for data harmonization on the continent. This platform will foster sustainability beyond the
lifespan of the HarmonAIze project and facilitate ongoing improvements and implementation in future projects.
The HarmonAize project has the potential to present a step-change in climate and health research within the
HE2AT Center, across the DS-I Africa initiative, and other projects, through developing and sharing innovative
data science tools to facilitate climate-health analyses. The project has the potential to accelerate the broad
transformation of research into public health policy and interventions, on the African continent and beyond.

Public health relevance
Project Narrative The HarmonAIze project will deliver a generalizable, semi-automated toolkit to aid health data harmonization and linkage with climate data using novel AI approaches, thereby addressing key barriers to the large-scale re- analysis of health data across all research topics, and markedly accelerating progress in the field of climate and health. We will accelerate and extend the achievement of the HE2AT Center and DS-I Africa’s objectives, by building data science and leadership capacity in early-career investigators, supported by a mentorship network within the HE2AT Center consortium. Sharing the open-source toolkit through the eLwazi Open Data Science Platform, and piloting implementation of the kit within other DS-I Africa Research Hubs, will maximize impact within the DS-I Africa consortium, and advance public health research more broadly.